CARDIOVASCULAR RISK IN HEALTHY AND POSTMENOPAUSE PHYTOESTROGEN USERS

Test hypothesis that phytoestrogens will improve HDL-C levels, improve bone mineral density and improve psychosocial outcomes as evidence by less depressed mood, greater life satisfaction and quality of well being. Secondary hypotehses are that phytoestrogens will be favorable to total cholesterol levels, glucose, insulin, coagulation factors, blood pressure, fat distribution, vasomotor and other menopausal symptoms.